Investigating the impact of chronic stress on distinct axes of dopamine signaling

Project Summary
Impairments in recognizing and pursuing potential rewards, and detecting and avoiding potential threats, are
core elements of psychiatric disease and often both present in a single individual. However, the neurobiological
mechanisms underlying these impairments, and whether the neurobiology involved in each domain is distinct or
related, remains largely unknown. In rodents, chronic stress induces changes in reward and threat processing,
but the neural bases of these changes, and how they interact with one another, are unresolved. Recently, our
lab has developed two naturalistic “approach/avoidance” paradigms in which potential reward and potential
threat are simultaneously presented, causing a conflict between motivation to approach reward and avoid
threat. These paradigms are an ideal setting to test how chronic stress influences reward approach, threat
avoidance, and the interaction between the two. We discovered that a distinct population of midbrain dopamine
neurons which project to the tail of the striatum (TS) facilitate threat avoidance in these paradigms. In past work,
we have extensively characterized that midbrain dopamine neurons which project to the ventral striatum (VS)
underlie response to and conditioning for reward, and complementary work suggests this population facilitates
reward approach. How these distinct dopaminergic populations are affected by chronic stress, and whether this
accounts for stress-induced changes in reward approach and threat avoidance, is an open question.
Interestingly, our preliminary data suggests that different chronic stressors shift reward approach/threat
avoidance behavior in unique ways. I hypothesize that these changes in behavior are underpinned by changes
in the balance of activity between VS-projecting and TS-projecting dopamine neurons. Aim 1 will characterize
how varied chronic stressors impact approach/avoidance behavior, using machine learning approaches
DeepLabCut and MoSeq to conduct this investigation in a fine-grained, data-driven manner. Aim 2a will explore
the contributions of VS-projecting and TS-projecting dopamine neurons to approach/avoidance behavior, how
these subsystems interact to produce a behavioral decision in healthy mice, and whether aberrations in one
subsystem or another account for altered behavior in stressed mice. Aim 2b will test whether optogenetic
manipulations of VS-projecting or TS-projecting dopamine neurons are sufficient to restore approach/avoidance
behavior in stressed mice to the range seen in healthy controls. The translational implications of this work are
significant. Should alterations in reward and threat processing following stress involve distinct dopaminergic
subcircuits with opposing behavioral effects, treatments may be most effective when targeting the specific
subcircuit underlying a particular behavioral presentation, rather than changing dopamine signaling universally.

Public health relevance
Project Narrative. Adaptive functioning in all animals, including humans, requires a careful balance between recognition and pursuit of potential rewards (food, shelter, and social interaction, among others) and detection and avoidance of potential threats (theft, natural disasters, and interpersonal rejection, for instance). Many psychiatric diseases involve impairments in one or both of these processes, symptoms which significantly impair functioning and cause considerable distress. The present work will investigate the neural basis of alterations in reward and threat processing following chronic stress in mice, with the goal of understanding and ameliorating the changes in brain circuitry that lead to impairments in reward and threat processing.